Administrative Core

Project Summary
The Administrative Core of the University of Washington (UW) Research and Engagement on
Adaptation for Climate and Health (REACH) Center will provide the supportive framework for
Center activities and provide the cohesion to ensure long-term success. The Core provides
management and oversight of the many functions that allow the Center to fulfill its objectives
and provides a supportive infrastructure that encourages collaboration and creativity, builds
capacity, and facilitates open lines of communication.
The specific aims of the Administrative Core are to:
● Provide fiscal oversight, record-keeping, and reporting for the Center and ensure
compliance with all institutional and NIH requirements.
● Promote Center integration and coordination across the transdisciplinary teams.
● Facilitate effective communication and ensure effective research translation.
● Coordinate the Center’s function and evaluation.
● Cultivate the careers of early- and mid-career investigators.
● Ensure commitments to diversity, equity, and inclusion are achieved.
● Oversee the data infrastructure and management plan.
The Director has final decision-making authority on resource allocations that deviate from the
original proposal plans, with input and advice from the Executive Committee. The Project
Administrator, with oversight from the Director, manages all fiscal aspects and compliance
requirements. Situations that could require re-allocation of resources include budget cuts, carry
forward of unexpended resources, and unanticipated costs that were incurred. Dispute
resolution will be accomplished by direct discussions between the Director and the Director of
the affected Core, with guidance from the Center Administrator. Larger issues that cut across
multiple Cores are brought before the Executive Committee for their input.
The Administrative Core stays informed about changes in reporting requirements, record
keeping, and grant guidelines to ensure accurate and compliant reporting. The Core will assist
in compiling Annual Progress reports and overseeing all IRB documentation. At least three
Center faculty members will attend the NIH annual meetings of PI investigators.